Full Spectrum Cell Sorter with Imaging Enhancement for Boston University Flow Cytometry Core Facility

B. Project Abstract
The Boston University (BU) Flow Core seeks funding to acquire the BD FACSDiscover S8, a
state-of-the-art spectral cell sorter with advanced imaging capabilities, to replace our aging BD
FACSAria II, which is critical for our high-demand cell sorting applications. The current
instrument, heavily utilized by over 90 laboratories and integral to multiple NIH-funded projects,
is outdated and will no longer be supported by the manufacturer after December 2024. The BD
FACSDiscover S8 will provide unmatched accuracy in cell sorting and the ability to integrate
imaging and spectral cytometry, essential for our advanced research applications.
Our research programs, including studies on pneumonia, sepsis, HIV, lung and breast cancer,
adipose tissue dynamics, and immune cell interactions, require high-quality cell sorting that the
current equipment can no longer reliably provide. The BD FACSDiscover S8 will enable
seamless transfer of optimized panels from the Cytek Aurora analyzer to a sorting platform,
allowing us to sort up to six populations simultaneously and improving the quality of sorted cells
by excluding debris and dead cells through engaging imaging features. This capability is crucial
for ongoing NIH-funded projects and future research endeavors.
The acquisition of the BD FACSDiscover S8 is essential for maintaining the productivity and
quality of our research. It will support studies on neutrophil heterogeneity in pneumonia,
immunophenotyping myeloid cell populations, and the dynamic behavior of adipose progenitor
cells (APCs) in response to environmental stimuli. The instrument's advanced imaging
capabilities will enhance our ability to conduct single cell transcriptomics experiments and other
downstream analyses, providing deeper insights into cell morphology and interactions.
Overall, the BD FACSDiscover S8 will significantly advance our research by enabling high-
quality cell sorting and comprehensive phenotypic analyses. This will drive forward our
understanding of complex biological processes and contribute to the development of novel
therapeutic strategies, ensuring that the BU Flow Core continues to meet the high demands of
its research community.

Public health relevance
A. Project Narrative To support research across various disciplines, including stem cell biology and cancer biology, Boston University Medical Campus (BUMC) research community needs access to efficient cell population isolation methodology. The BU Flow Core, which houses both of BUMC’s cell sorters, faces challenges as one sorter instrument, the BD FACSAria II, is outdated and unsupported. Therefore, we seek funding to replace it with a new BD FACSDiscover S8 sorter to sustain BU's scientific endeavors.